Psychosocial Factors Associated with Parental Self-Efficacy in Adolescent Suicide Prevention

PROPOSAL SUMMARY-ABSTRACT
Adolescent suicide is a growing public health problem and a leading cause of death in the US. Rates of
adolescent suicide and suicidal behavior have been on the rise for the last two decades increasing
disproportionally among Black adolescents. Increasing rates of suicidal behaviors have also led to a surge in
adolescent ED visits. Parents play a central role in suicide prevention efforts by protecting their children from
self-harm and promoting their mental health following discharge from the ED for suicidal behavior (SB) when a
child’s risk for recurrent SB is greatest. Parents’ needs in caring for suicidal adolescents are often not
considered yet they hold primary responsibility for ensuring their child’s safety after ED discharge. Parental
self-efficacy (PSE) is a parent’s belief in their ability to fulfill their parenting role effectively and is a powerful
predictor of parenting competence and child well-being. In the context of this study, PSE to prevent SB is
conceptualized as a parent’s perceived ability to support their child in crisis, keep them safe, and prevent future
SB. This convergent mixed-methods study seeks to understand the psychosocial factors associated with SB
prevention self-efficacy among parents caring for adolescents following an ED visit for SB by addressing the
following specific aims: 1) Examine associations between parent-level psychosocial factors, adolescent
suicide-related characteristics, and parents’ SB prevention self-efficacy, 2) Based on individual parent
interviews, understand how psychosocial and contextual factors influence parents’ SB prevention self-efficacy
with an emphasis on understanding potential differences in the experiences of Black parents; and 3)
Integrating results from Aims 1 and 2, identify potential strategies for building parents’ SB prevention self-
efficacy in caring for an adolescent following an ED visit for SB. The study will be guided by a parent advisory
group and leverage the research infrastructure of a larger PCORI-funded adolescent suicide prevention study
in the Johns Hopkins Hospital Pediatric ED. Aim 1 (quantitative) will use cross-sectional data (n=125; 60%
Black/African American); Aim 2 (qualitative) will include individual interviews (sub-sample of parents n=20;
50% Black/African American). Correlations and multiple linear regression models will be used to test the
quantitative data; a content analysis approach will be used to analyze the qualitative data. Data from Aims 1
and 2 will be integrated to compare parents’ qualitative descriptions and quantitative scores and assess for
potential differences in parents’ SB prevention self-efficacy based on parent-level psychosocial factors,
adolescent suicide-related characteristics, and between Black/African American and White parents. Results of
this study will fill a clinical research gap with the future goal of developing interventions to bolster the protective
role of parents in preventing adolescent SB. The proposed study addresses the NIMH’s Strategic Plan,
Strategic Framework for Addressing Youth Mental Health Disparities, and recent calls to identify risk and
protective factors for youth suicide and prevention.

Public health relevance
PROJECT NARRATIVE Adolescent suicide is a growing public health problem and the rates of suicide deaths and suicidal behavior in the US have been on the rise for the last two decades. Parents play a central role in suicide prevention efforts, particularly during the critical period following ED discharge, but little is known about how to equip and support parents or address their needs while caring for an adolescent with suicidal behavior. This proposal is the first step in a research trajectory designed to address this critical gap in the field of adolescent suicide prevention research and inform the development of interventions to bolster the protective role of parents in preventing suicidal behavior and adolescent suicide.